Neuroimaging Core

Project Summary: Neuroimaging Core
The Oregon Alzheimer’s Disease Research Center (OADRC) has a 20+ year history of substantive longitudinal
neuroimaging research, with a focus on healthy aging, mild cognitive impairment (MCI) and MRI markers of
early dementia in the elderly, and includes an extensive longitudinal database of over 3700 MRI’s from over
1000 subjects, most of whom are 80 years of age, or older. The OADRC has implemented advanced imaging
sequences and analysis techniques to further our understanding of MRI markers associated with age-related
changes in cognitive and motor function, including healthy aging, early cognitive decline, and imaging markers
of vascular disease and white matter integrity. These advances have allowed the OADRC to collaborate and
foster MRI research in brain aging both within and outside of OHSU. The OADRC Neuroimaging Core
consolidates the long-standing history of longitudinal neuroimaging of the oldest old, and more recent
collaborations and innovations in neuroimaging. The Neuroimaging Core supports in vivo 3T MRI acquisition
and analysis of studies investigating Alzheimer’s disease and related disorders, with an additional focus on
vascular cognitive impairment and dementia (VCID). In addition to advanced in vivo MRI protocols, the
Neuroimaging Core has developed a 7T post-mortem (PM) imaging protocol of human brain tissue for the
targeted sampling of MRI-defined regions of interest for histopathology. Imaging research themes supported by
the core will include: 1) healthy aging and early imaging markers of cognitive impairment, 2) the role of
cerebrovascular disease on cognitive function and dementia risk, and 3) treatment and prevention trials aimed
at maintaining cognition in the elderly. The Neuroimaging Core will provide essential resources to pursue and
develop novel MRI sequence and analysis techniques for current and future aging studies and facilitate our
ability to advance our understanding of age-related cognitive changes. The core will continue to consolidate
and substantially build upon previous advances that include both in vivo and PM MRI methods to detect early
brain changes associated with cognitive decline in elderly at risk for dementia. The Specific Aims of the
proposed Neuroimaging Core are:
1. To obtain and make available for research, state of the art, neuroimaging acquisition and advanced
MRI processing from OADRC subjects, including: healthy controls, MCI, and those with AD and other
dementias,
2. To obtain and make available for research, neuroimaging data on OADRC subjects, and
3. To foster collaborative research involving neuroimaging, and enhance utilization of other core
resources.
!